Iowa- AFRPS Maintenance and Mutual Reliance

Project
Summary
Our focus will be on maintaining our compliance with the Animal Feed Regulatory Program
Standards (AFRPS) and to improve our processes under the AFRPS standards by developing
policies and procedures, strengthening collaborations, and conducting program self-
assessment to maintain and improve conformance with the standards. We intend to focus on
4 main areas to reach these goals.
The first area will be to ensure we maintain our full implementation by working closely with the
FDA for both planning and determination of regulatory activities to be taken. In addition, we will
undergo and respond to regular assessments to maintain our conformance to the standards.
The second area of focus will be on continuous improvement. Through the annual Face to
Face Meetings and attendance at other meetings (AAFCO, Feed Administrators Seminar, etc)
we will learn best practices from other state regulatory agencies as well as sharing our own
with them. By evaluation and implementation of those best practices we should be able to
continuously improve our program and streamline our processes.
Thirdly, we will support the Laboratory Flexible Funding Model (LFFM) for the Iowa Laboratory
Facility by coordinating with FDA on our response to violative samples, working with the
laboratory to collect samples for them that meet the definitions of the LFFM. In addition, we will
use the correct resources to work with both the laboratory and FDA to investigate violative
samples. The Iowa Laboratory Facility is a FERN laboratory and so capacity evaluation
should be adequate.
Finally, we will continue to develop our auditing program. We currently have one qualified
auditor, but plan to identify and train a second so that we will be able to do all required audits
in-house by the end of the 3 year period covered by this grant.
Meeting these combined goals will help the Commercial Feed and Fertilizer Bureau to protect
public health by having policies and procedures in place to maintain a high quality animal feeds
regulatory program.

Public health relevance
Project Narrative The dual focus will be to maintain our compliance with the Animal Feed Regulatory Program Standards (AFRPS) and to improve our processes under the AFRPS standards at IDALS. This will require working with FDA closely to ensure inspections are conducted in such a way as to be sufficient to take regulatory action, continuing to identify and address areas in compliance to the AFRPS standards that could be improved, supporting the laboratory in their commitment to the Flexible Funding Model, and continuing to develop our auditing program with a goal of being able to do auditing completely in-house by the end of the three-year period. Achieving these goals will help the Commercial Feed and Fertilizer Bureau to protect public health by having policies and procedures in place to maintain a high quality animal feeds regulatory program.